Multiplex Engineered Human Lymphocytes for Therapeutic Protein Delivery

Abstract.
Recessive dystrophic epidermolysis bullosa (RDEB) is a severe autosomal recessive disease caused by
collagen type VIIa (COL7A1) gene mutations. RDEB is characterized by absent/defective COL7A1 (C7) protein
deposition causing severe blistering, mucosal tissue damage, and aggressive squamous cell carcinoma. The
University of Minnesota serves as a leading treatment referral center for this inherited disorder. Palliative care
is non-curative and cellular therapy options include autologous or allogeneic local and/or systemic infusion of
keratinocytes, fibroblasts, mesenchymal stromal cells (MSC), or hematopoietic stem/progenitor cells (HSPC).
None of these currently employed treatment options resolve the full pathological spectrum of RDEB. Active
wound areas persist, and mucosal disease remains highly refractory to intervention contributing to significant
morbidity. Keratinocytes and fibroblasts, the primary C7 producing cells, show limited migration and persistence
following localized injection. MSC and HSPC have broad circulatory potential, however, they produce
comparatively low levels of C7 and residence in the skin or mucosa is not well established. Thus, it is essential
to develop more efficacious cellular therapies capable of accessing skin and mucocutaneous tissues. γδ T cells
are abundant within skin and mucosa, and due to their MHC-unrestricted nature are compatible with allogeneic
transfer, however they do not naturally produce C7. Our innovative approach will employ precision genome
modification using CRISPR/Cas9 to engineer γδ T cells to produce high levels of endogenous C7. We
hypothesize that the tissue migratory properties of γδ T cells—particularly to the skin and mucosa—as well as
their demonstrated allo-compatibility, make them uniquely suited for therapeutic delivery of C7 protein. In Aim 1
we will define a genome engineering strategy to confer high C7 expression, enhanced skin homing, and reduced
inflammatory/cytotoxic capacity to primary human γδ T cells. In Aim 2 we will evaluate the ability of engineered
allogeneic γδ T cells to home to skin and mucosa, deposit C7, and ameliorate pathology in an immunodeficient
mouse model of RDEB. Further, we will test the effect of zoledronate induced in vivo expansion of the engineered
Vγ9Vδ2 T cell subset on therapeutic efficacy. Our approach is a highly novel and innovative allogeneic strategy
designed to address key limitations of current cellular therapies for RDEB. The application of CRISPR/Cas9 in
γδ T cells represents a novel engineering and protein delivery strategy with translational potential for RDEB,
other inherited mucocutaneous disorders, and a multitude of diverse disorders treated by cell/stem cell
transplant.

Public health relevance
PUBLIC HEALTH RELEVANCE Inefficient delivery of type 7 collagen (C7) to skin and mucosa limits treatment of recessive dystrophic epidermolysis bullosa (RDEB). Overexpressing COL7A1 using current vector systems is restricted by the large size of the COL7A1 cDNA, however recent advances in genome editing have made it possible to engineer cells to express high levels of endogenous COL7A1. We will leverage this new technology to engineer a unique population of skin and mucosa resident immune cells to produce and deliver therapeutic C7 to target tissues, thus outlining a highly translational approach that is transferrable to other disorders and will lead to new discoveries to improve human health.